TASK AREA A: IN VITRO SCREENING AGAINST BACTERIAL PATHOGENS

This contract provides in vitro testing of potential anti-bacterial (or anti-fungal agents), efficacy to combat the effects of toxins produced by bacteria and fungi, maintenance of bacterial, fungal and toxin stocks, and the development of related assays.